2/2 Discovery and validation of neuronal enhancers associated with the development of psychiatric disorders

In this project, we will develop novel methods for finding brain-specific enhancers, build
regulatory networks, deconvolve brain-region-specific regulation, and relate differential
enhancer signals to variations in the human population. We will then apply these analytical
methods to the psychENCODE data corpus, integrating these data with GTEx, ENCODE, and
CommonMind data, annotating GWAS SNPs associated with psych disease, prioritizing the
discovered regulatory elements for validation, and visualizing all psychENCODE data in an
integrated fashion. We will then validate these predicted regulatory elements using large-scale
genomic assays in neuroblastoma cells, iPSC cells, and neuronal precursor cells differentiated
into neuronal lineages, and using a microfluidics platform capable of culturing neuronal cells and
neuronal organoids. The results from these studies will further our understanding of the genetic
regulatory basis for neuronal function in both normal and neuropsychiatric disease states.

Public health relevance
The data generated by the psychENCODE Consortium are a pre-eminent, centralized resource for studying the human brain. We will develop cutting-edge analytical methods and apply them to the psychENCODE data corpus to identify regulatory elements and then validate them using large-scale genomic assays in neuronal cells and organoids. Our results will further our understanding of the human brain in the healthy state and neuropsychiatric diseases.